Quantitative Imaging: Biostatistics and Medical Physics

Quantitative Imaging: Biostatistics and Medical Physics (SR-C). This Specialized Resource provides support for a wide range of imaging (MRI, nuclear and optical imaging) procedures and statistical functions for the clinical trials in ICMIC-3 as well as all the pre-clinical animal research for all Research Projects and Developmental Projects. The tasks and services to be performed by SR-C fall into six broad categories; 1) to make additional computational and centralized Image storage facilities available to lCMIC-3 investigators thereby facilitating data sharing between projects; 2) to make specialized image processing and display software available, allowing the sharing of the software licenses and centralizing support; 3) to provide software development capabilities for the performance of specialized processing and analyses including the automation of bulk processing tasks, format conversions and the development of new algorithms; 4) to consult on issues regarding imaging protocols, optimal acquisition settings, quantitation and on the modeling of tracer kinetics; 5) to provide biostatistical expertise in the design and analysis of research studies and to conduct statistical analyses and modeling of data generated by those studies; and 6) to conduct research leading to the development of new capabilities of common benefit to the iCMlC-3 projects.

Public health relevance
This resource provides essential support for all 4 of the research projects and in addition the developmental projects. It provides the expertise necessary for consolidating the multi-modality pre-clinical small animal imaging studies proposed as well as quantitative imaging requirements of the clinical imaging studies projected in RP1 and RP4 with novel radiopharmaceuticals.